A platform for monitoring the efficacy and optimal dosing of long-acting ART

Project Summary/Abstract
The rapidly emerging modalities of long-acting antiretroviral therapy (ART) for treatment and prevention
are based on a one-size-fits-all dosing strategy despite these being our first experiences in real-world settings,
where patient management challenges are common. To address this issue, we propose a novel pharmacologic
monitoring platform for long-acting ART in real-world settings. We aim to develop and validate at-home self-
collections and point-of-care (POC) testing for quantitative cabotegravir/rilpivirine (CAB/RPV) concentrations to
support patient management and inform optimal use of long-acting ART and PrEP, with the vision that this
platform will be widely implementable and able to accommodate next in line long-acting HIV therapies in
development.
CAB/RPV concentrations were influential in tightly controlled trials, even with a 1% virologic
breakthrough rate. Among 1,039 participants, CAB/RPV concentrations varied by more than 10-fold at a single
4-week post-injection time point. Of 13 observed HIV breakthroughs, none occurred when concentrations of
both drugs were above the median, no matter what other risk factors were present –including archived
resistance mutations. On the other end of the spectrum, some patients achieved CAB/RPV concentrations
well-above expected levels and could comfortably extend dosing beyond Q8W, but this possibility was not
adequately investigated. In practice, CAB/RPV concentrations will be more variable than in tightly controlled
trials because real-world patients miss appointments, change providers, and leave/reenter care. Additionally,
within-person variability from injection-to-injection is unknown. To address these gaps and needs, we propose
the following specific aims: Aim 1. Validate at-home self-collections and POC testing. Building on our
preliminary data using at-home self-collections and POC testing via miniature mass spectrometry, we will
develop and optimize suitable assays using samples from 30 persons with HIV (PWH) receiving Q4W or Q8W
long-acting injectable CAB/RPV. Assays will be validated using FDA bioanalytical guidance. Aim 2. Classify
CAB/RPV concentrations in a real-world longitudinal cohort. Through longitudinal blood collections in 50
PWH receiving Q4W or Q8W long-acting injectable CAB/RPV, we plan to classify drug concentrations into low,
expected, and high categories and define specific pharmacokinetic (PK) parameters, including within- and
between-person variability. Aim 3. Establish pharmacokinetic strategies for personalized dose intervals.
We will identify the ideal drug concentration testing strategy to determine patient-specific PK, and in turn, the
optimal dose frequency to achieve goal concentrations. We envision an easy-to-use interface where clinicians
will input drug concentrations to calculate personalized dosing. This application is timely and provides
innovations to keep pace with the rapidly emerging long-acting era.

Public health relevance
Public Health Relevance Statement (Project Narrative) While long-acting antiretroviral therapy (ART) is effective, its pharmacology in the real world, where patient management problems have emerged, is unclear. This application will address this gap and develop new real-time and point-of-care measurements of drug concentrations in PWH receiving long-acting ART.